Role of Macrophages on Tissue Remodeling Following Cochlear Implantation

Project Summary
Cochlear implant (CI) electrode arrays are made of platinum (Pt) wires and contacts encased in
polydimethylsiloxane (PDMS, silicone) housing. These materials provide mechanical stability and flexibility
critical to the long-term function of the device. However, they also induce a foreign body response and fibrosis
that have detrimental effects. For example, the fibrotic capsule that eventually encases all CI electrode arrays
leads to increased impedances and signal broadening which decreases the effectiveness of the device.
Further, intracochlear fibrosis is implicated in the loss of acoustic hearing that can occur months to years after
implantation. As candidacy for CI is rapidly expanding, including many patients with significant residual
hearing, there is an urgent need to understand the fundamental processes that lead to intracochlear fibrosis.
Macrophages are recognized as key, central regulators of the foreign body response to biomaterials in other
tissues and our preliminary data demonstrate vigorous macrophage recruitment following implantation of CIs.
We hypothesize CI biomaterials activate macrophages leading to the recruitment of fibroblasts and
fibrosis/encapsulation of the biomaterials and that electrical stimulation modulates this macrophage response
dependent on the stimulus level and timing of onset. In Aim 1, in vitro culture models are used to explore the
differential effect of PDMS and Pt on macrophage recruitment, activation, and regulation of cochlear fibroblast
proliferative and synthetic functions. Aim 1 also investigates the temporal and spatial activation and recruitment
of macrophages following cochlear implantation using a reporter mouse model. Aim 2 examines the role of
macrophages in fibrosis/neo-ossification following cochlear implantation. First, we test the requirement of
macrophages for intracochlear fibrosis following CI using a mouse line that allows conditional and selective
depletion of macrophages. Next, implanted mice are treated with a specific CSF1R inhibitor to deplete
macrophages as a preclinical translational model. Finally, a CX3CR1 null mouse is used to determine the
effect of fractalkine signaling on post-CI fibrosis. Aim 3 determines the effects of varying levels of electrical
stimulation and effects of timing of electrical stimulation onset on macrophage recruitment and intracochlear
fibrosis. The proposed work provides a rigorous investigation of the effects that specific biomaterials, insertion
trauma, and electrical stimulation exert on macrophage responses and the regulation of the fibrosis in the
cochlea. The long-term impact of the work is to identify specific, effective, and durable strategies to limit
fibrosis following CI or other injuries to the cochlea.

Public health relevance
Project Narrative: Cochlear implants are one of the most successful biological implants, and while these devices provide hearing to people who have lost significant hearing, most ears implanted with a CI have inflammatory reactions to the device that negatively affects their performance. The implant is made of materials that cause an inflammatory reaction that results in scar formation and limits the ability of the device to provide optimal hearing. In the proposed work, we will perform experiments in mice to investigate the effects of the biomaterials that are used to make cochlear implants and the effects of electrical stimulation to understand how these aspects of cochlear implantation influence inflammation and scar formation in the cochlea.